Use of Wearable Sensors to Assess Prosthetic Alignment in Veterans with Unilateral Transtibial Amputations

Veterans with transtibial amputation require a prosthesis to walk and are at an increased risk of secondary
injury, discomfort, and reduced quality of life. Proper prosthetic alignment can reduce these risks and improve
functional ability and comfort in individuals with transtibial amputation. Currently, prosthetists (clinicians)
subjectively align a prosthesis, and this may require several clinical visits. Subjective alignment relies on
prosthetists’ experience and visual inspection of walking, which is prone to errors and time consuming. Thus,
there is an urgent need to develop objective tools for prosthesis alignment. We aim to develop a novel method
to [assess] prosthesis alignment accurately, precisely, and cost-efficiently using wireless sensor technology,
which could improve quality of life and reduce secondary injury risk for the millions of prosthesis users in the
United States. The goal of this study is to determine the accuracy and precision of using wearable sensors
combined with an algorithm to assess prosthesis alignment in 10 Veterans with transtibial amputation.
[We will ask 10 Veterans with transtibial amputation to walk on a force-treadmill at 1.25 m/s while they use
a prosthesis with neutral alignment and that varies by 3° and 6° in one of three planes, the sagittal, coronal,
and transverse planes, for a total of 13 prosthesis alignments. For each alignment condition, we will determine
the accuracy and precision of using inertial measurement units (IMUs) combined with a numerical algorithm
to estimate dynamic-to-static angle (DSA) of the prosthesis and the biological shank during walking in 10
Veterans with unilateral transtibial amputation (Aim 1), where DSA provides information regarding the
orientation of the prosthesis and the biological shank. We will also determine the accuracy and precision of
using IMUs combined with a numerical algorithm to estimate inter-limb symmetry indices of step length, step
frequency, and contact time, which are important discrete temporal-spatial parameters during walking in 10
Veterans with unilateral transtibial amputation (Aim 2). We will compare results estimated using IMUs with
results calculated using traditional gold-standard measurements of 3D motion capture and ground reaction
forces. We will also investigate the association between angular changes in prosthesis alignment and DSA
and interlimb symmetry indices (Aim 3).] We hypothesize that the IMU method will provide accurate (root-
mean squared error [RMSE]<6°) and precise (inter-class correlation coefficient [ICC]>0.75) estimations of
DSA for both legs and inter-limb symmetry indices (mean absolute percentage error [MAPE]<10%, ICC>0.75)
of temporal-spatial parameters. We also hypothesize that changes in prosthesis alignment will result in
significant differences in DSA using the IMU method and motion capture measurements. We hypothesize
that changes in prosthesis alignment will result in significant differences in interlimb symmetry index of step
length, step frequency, and ground contact time. [If our results suggest that the IMU method does not provide
accurate and precise estimations of DSA or symmetry indices, we will consider using a more sophisticated
prediction model (e.g. machine learning) to predict DSA using IMUs.]
The outcome of our research is the development of a novel method that uses wireless IMU sensors to
[assess] prosthesis alignment accurately (comparable accuracy with camera-based motion capture system
and force plate ground reaction force system), quickly (within a single visit), and cost-efficiently (<$200). [We
also expect that this project will provide data to support a larger grant proposal to conduct a study that
investigates the relationship between prosthesis alignment and comfort level, walking symmetry, and
secondary injury risk in Veterans with amputations.] In the long term, the proposed IMU method could improve
the alignment process and thus maximize Veterans’ functional independence and quality of life, as well as
reduce secondary injury risk.

Public health relevance
Previous studies suggest that Veterans with a leg amputation who use a prosthesis have impaired physical function, which could increase the risk of osteoarthritis, leg/back pain, and diabetes/obesity. The alignment of a lower limb prosthesis, which is the orientation of prosthetic components with respect to the socket, affects the risk of secondary injury and physical function of Veterans with leg amputation. Currently, there are no objective methods to assess prosthetic alignment in Veterans with a leg amputation. Thus, we will develop an accurate, precise, and cost-efficient measurement method to objectively [assess] prosthetic alignment in a clinical setting. In the long term, [this approach could be used to investigate the relationship between prosthesis alignment and comfort, secondary injury risk, and quality of life in Veterans with lower limb amputation. We ultimately aim to advance measurement technology and rehabilitation to reduce discomfort and improve the physical function and quality of life of Veterans with an amputation.]